Better Together: Integrating MOUD in African American Community Settings

Racial disparities in engagement and retention in treatment with medication treatment for opioid use disorder
(MOUD) are profound and persistent and have devastating consequences. Black/African American persons
have experienced the fastest increases in opioid overdose deaths nationally since 2013 and now have higher
rates of overdose deaths than whites [1,2]. COVID-19 has accelerated overdose deaths especially among
Black/African Americans: during 2020, the number of Black persons dying from an opioid overdose increased
by 45% compared to the previous year, nearly double the increase for white overdose deaths [3]. Despite the
great need for MOUD, Black/African Americans are substantially less likely than whites to receive MOUD,
especially buprenorphine, and have substantially lower rates of MOUD treatment retention [4-8]. These
differences in MOUD treatment engagement and retention persist even when controlling for socioeconomic
factors and despite reducing barriers to MOUD (e.g., expanding Medicaid eligibility, eliminating co-pays or prior
authorization requirements) and increasing its availability in a broad range of medical settings (e.g., medical
offices, clinics, federally qualified health centers, and Emergency Departments) [8-13]. Our own and others’
research identify that stigma, medical mistrust, fear of legal consequences, and bias and misunderstanding
about MOUD contribute to underutilization of MOUD in Black/African American populations [14-17]. To address
these barriers, outreach, engagement, and reengagement by community-based Peer Recovery Specialists
(PRS, trained individuals with shared lived experience of SUD recovery), providing MOUD in a broader range
of settings and by telemedicine, and a collaborative care model integrating provision of substance use disorder
treatment generally or MOUD with buprenorphine (supported by telemedicine) in trusted, community sites,
including churches or faith-based or secular community organizations, have been found to be feasible and
attractive to Black/African American persons with untreated OUD [18-26]. Additional research is needed,
however, to evaluate barriers and facilitators for implementation of a collaborative care model integrating
provision of MOUD with buprenorphine and provision of PRS services in community-based sites and to
evaluate the effectiveness of this MOUD care model compared to MOUD with buprenorphine provided in
medical offices or clinics for urban Black/African Americans with OUD.

Public health relevance
This supplement leverages the Great Lakes Node (GLN) of the NIDA-supported National Drug Abuse Clinical Trials Network (CTN). This node will draw on an experienced set of investigators to participate in the Better Together (ICC-MOUD) trial proposed jointly by Howard University, University of Miami, and University of Illinois Chicago. The work conducted in Year 1 will launch the trial and involve completion of the protocol drafting, obtaining approvals from requisite CTN and CCTN entities, and formalization of partnerships with community organizations serving the Black community in Chicago.